Step-wise order of assembly of histone proteins into nucleosomes in living cells

This Project Summary/Abstract was originally submitted with R35 GM148198 and is included here unchanged
to satisfy submission system requirements.
PROJECT SUMMARY
Most cellular functions are carried out by multisubunit protein complexes. Transcribe and translate as much as
you want, but odds are if your protein doesn't assemble properly with other proteins, the gene might as well be
off. As the final step in expression of most genes, protein complex assembly is hugely understudied, and it has
only recently become clear that the textbook model of diffusion-limited collisions between individual molecules
is inadequate. Septin proteins are found as cytoskeletal filaments in many eukaryotic cells and participate in a
wide variety of cellular functions. The building blocks of septin filaments are rod-shaped septin complexes
composed of distinct septin subunits. Multiple septins “compete” to occupy the same position in, and confer
specialized properties to, septin complexes, but it is not fully understood how specific subunits are “chosen” to
assemble the functionally appropriate complexes. How individual septins occupy specific positions within
complexes is one of the oldest questions in septin biology. Disease-causing septin mutations highlight the
importance of answering this question. Our lab is among the leaders in this field and in the next five years we
want to use the powerful tools we have developed in budding yeast to address specific knowledge gaps. For
other cytoskeletal proteins, achieving the conformation competent for complex assembly requires help from
molecular chaperones. How does chaperone-assisted de novo septin folding fit into the pathway of septin
complex assembly? Our recent work established the step-wise pathway of septin hetero-octamer assembly, and
identified septin-interacting chaperones that engage a septin-septin interaction interface and are necessary for
efficient septin folding. We will use a combination of genetics, cell biology and biochemistry to determine how
chaperone action sets the stage for septin-septin encounters during complex assembly. Recent studies show
that assembly of many complexes occurs co-translationally, and we find chaperone requirements for efficient
septin translation. To what extent is septin complex assembly co-translational? We will investigate septin-
chaperone and septin-septin interactions in the context of active translation. We previously identified key
residues in septin-septin interaction interfaces that mediate “partner recognition” during assembly and dictate
the subunit composition within complexes. An enduring mystery is how the two subunits at the “ends” of yeast
septin hetero-octamers always match. How do allosteric conformational changes across septin-septin interaction
interfaces direct the specificity of septin complex subunit composition? We will determine the mechanistic basis
of this phenomenon and determine the phenotypic consequences of inappropriate “mixing” of septin subunits
within complexes. Finally, it is not known how, once made, a septin complex is remodeled to incorporate new
subunits during cellular differentiation. We will determine the molecular mechanism by which yeast septin
complexes are remodeling during gametogenesis. These studies will provide valuable insights into how cells
assemble and modify septin complexes, with broader implications for multisubunit assembly in general.

Public health relevance
This Project Narrative was originally submitted with R35 GM148198 and is included here unchanged to satisfy submission system requirements. PROJECT NARRATIVE By uncovering molecular mechanisms by which important cytoskeletal proteins assemble into functional units in eukaryotic cells, the proposed research would contribute to fundamental knowledge about the nature and behavior of living systems.